REDESIGN AND REPROGRAMMING OF THE YEAST RESOURCE CENTER'S PRIMARY WEB SITE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Yeast Resource Center's main website (http://www.yeastrc.org/), which serves as the point of initial and returning contact with collaborators and the public at-large, was completely redesigned in the last reporting year. Most significantly, the new website was integrated with the YRC's online databases by providing a collaborator login box, as well as a Public Data Repository search box immediately on the front page of the new site. These boxes, along with site navigation appear consistently on every page in the web site. The site content and navigation were updated to include new information, such as new technologies and personnel;and to make information easier to find and the site easier to navigate.